Research Measures, Methods and Data Management Core

Project Summary- Research Methods, Measures, and Data Management Core
The Research Methods, Measures and Data Management (RMMDM) Core will advance the goal of the WashU-ACCERT center, to advance cancer control outcomes through community-engaged multi-level (individual, community, organization, and structure) research interventions that address the impact of access as defined by affordability (e.g., cost), availability of provider resources, attainability (ability to physically access services), accommodation (does access meet patient needs), and acceptability (patient/provider attitudes) on adverse cancer control outcomes, through three main functions. First, we provide distinct support in design, measures, and methods for the Community Responsive Research Program (CRRP), which includes the signature intervention and community-responsive projects within the Center. Second, the RMMDM Core is also responsible for supporting and administering Community Responsive Projects in the ACCERT Center. This includes engaging community partners in the selection, development, and adaptation of measures, as well as ensuring data sharing has community relevance and unintended consequences of data collection are monitored. RMMDM will work closely with the CRRP on administering community-responsive projects, including solicitation of projects, review and engagement with project leaders, and reporting back on progress, lessons learned, and outcomes to the community. We have also identified measures and a process to evaluate community engagement across the center, which will be implemented in collaboration with the Administrative Core. Third, we bring expertise in data management, data analysis methods for multi-level interventions, reporting of results, dissemination of research results through appropriate channels, and data sharing. The Aims for the Core are: 1. To provide distinct design, methods, measures, and related support for the CRRP and the signature multi-level trial within the Center. 2. To engage community members in the development and adaptation of measures, and support and administer Community Responsive Research Program in the ACCERT Center. 3. Manage study data, analyses, and prepare data summaries for scientific and community reporting, guide dissemination of results, and support data sharing requirements for the CRRP and signature project, and cross-center studies within our Center. Building on strengths of Siteman Cancer Center's Biostatistics and Qualitative Research Shared resource we bring rich and well-rounded quantitative and qualitative skills to support community-driven trials.